Targeted drug delivery for the treatment of cardiovascular disease and its clinical complications

Cardiovascular disease is the leading cause of death world-wide. Two main reasons for this are atherosclerosis,
which narrows major arteries, and thrombosis, which results in occlusive blood clots. Despite the ongoing health
burden, the translation of experimental therapies has stalled. A common challenge for therapies addressing
atherosclerosis and thrombosis is their poor localization in sites of disease such as atherosclerotic plaque and
thrombi. Thus, there is a pressing clinical need to develop novel targeting strategies to improve therapeutic
accumulation in these sites. I hypothesize that cell-mediated delivery of nanoparticle-encapsulated therapies will
improve site-specific therapeutic accumulation to treat atherosclerosis and thrombosis. To test this, I will employ
next-generation nanoparticle synthesis technologies (Flash NanoPrecipitation (FNP) and inverse FNP) coupled
with cell-mediated delivery for the directed delivery of therapies to atherosclerotic plaque and thrombi. FNP and
iFNP are new polymeric nanoparticle synthesis technologies that uniquely address challenges related to
scalability for manufacturing. To direct these nanoparticles to sites of vascular injury, I will employ cell-mediated
delivery. In this method, nanoparticles can be either loaded into cells ex vivo or decorated with ligands to exploit
interactions with internalization receptors specifically expressed on pertinent cells in vivo. Atherosclerosis and
venous thrombosis are two disease settings characterized by immunological cell infiltration; as such, they are
uniquely suited for the application of cell-mediated delivery of nano-encapsulated therapies. With respect to
atherosclerosis, circulating activated monocytes infiltrate into the inflamed arterial wall and differentiate into
macrophages, which are centrally important to atherogenesis. Notably, these cells over-express an
internalization receptor for folic acid: folate receptor-beta. Herein, I will develop therapeutic-carrying
nanoparticles conjugated to folic acid, with the goal of being specifically internalized by activated
monocytes/macrophages thereby employing these immune cells as delivery vehicles for the localization of drug
to atherosclerotic plaque. As oxidative stress is a key driver of atherosclerotic progression, I will focus on
delivering antioxidant interventions. An equally innovative strategy using exogenous neutrophils can be used to
treat thrombosis. A key challenge in our treatment of thrombosis is a time-dependent decrease in treatment
efficacy, as aging thrombi become increasingly difficult for clot-dissolving (thrombolytic) enzymes to penetrate.
Moreover, high doses of thrombolytic enzymes can lead to dangerous bleeding. I propose to address this
penetration issue by utilizing neutrophils as cell carriers of thrombolytic proteins encapsulated in polymeric
nanoparticles. Neutrophils actively infiltrate thrombi, and can be rapidly loaded ex vivo with polymeric
nanoparticles. Employing neutrophils as a delivery vehicle would address the issue of clot penetration and could
circumvent the problem of bleeding. Overall, my project aims to develop novel cell-mediated therapeutic delivery
platforms with the goal of preventing atherosclerotic plaque progression and treatment of thrombosis.

Public health relevance
Cardiovascular disease is a leading cause of death worldwide and in the USA with this due to two key underlying reasons: 1.a progressive disease called atherosclerosis and 2.thrombosis. The adequate localization of therapeutics to atherosclerotic plaque or thrombi remains a challenge for current therapies. My goal is to study the targeted delivery of therapeutics to atherosclerotic plaque and thrombi, using cell-mediated therapeutic delivery coupled with next-generation nanoparticle synthesis technologies.